Genetic characterization of atypical parkinsonism

Understanding the molecular pathogenesis of atypical parkinsonism is critical for identifying targets that could be translated into therapies. We have learned that the genetic contributions to these age-related neurodegenerative syndromes can be complex, involving both common and rare risk variants. Our mission is to define the genetic architectures of atypical parkinsonism syndrome using modern genomic tools. Additionally, we strive to leverage this knowledge to understand the broader neurodegenerative disease spectrum. Over the past year, we have expanded our efforts to integrate proteomic data in our systems-level analyses, enabling deeper insights into disease-related networks and pathways. By combining proteomic signatures with other modalities, we are advancing the development of robust, multi-modal biomarkers capable of diagnosing and differentiating neurodegenerative diseases with great precision. These advances not only strengthen disease modeling but also lay the groundwork for targeted therapeutic strategies.